PAPILLOMAVIRUS AND ORAL CANCER--A CASE-CONTROL STUDY

Human papillomavirus (HPV) is prevalent in the oral mucosa and may be involved in the etiology of oral squamous cell carcinoma. No study to date has evaluated HPV as a risk factor for oral cancer. The proposed research is a case-control of 65 patients registered at the University of Texas M.D. Anderson Cancer Center with previously untreated, histologically confirmed oral squamous cell carcinoma and 74 age-, sex- and race-matched controls. The cases and controls have been accrued, and medical history questionnaire data have been collected and automated. Collection of laboratory data concerning the prevalence of HPV and mutagen-induced chromosome breakage was recently completed. The measurement of the antibody response to HPV will be accomplished using HPV-derived synthetic peptides as antigens in an enzyme-linked immunoassay. The serologic response data and HPV prevalence and typing data will be evaluated as risk factors for oral cancer in univariate analysis. Data from self-administered risk factor questionnaires and mutagen-induced chromosome sensitivity data will be integrated with the HPV data. The results of the proposed study will provide a basis for larger prospective studies to evaluate HPV infection as a possible marker for tumor development.